The SMAD3 signaling network in coronary artery disease risk

Genome wide association studies (GWAS) have identified the transforming growth factor-b (TGFB) pathway as
a prominent causal mechanism of coronary artery disease (CAD) risk. Through support provided by this
funding mechanism, we have shown that disease protective TGFB canonical signaling factors SMAD3 and
ZEB2 promote formation of disease-related transition smooth muscle cells (SMC) to a fibroblast-like
phenotype, producing cells we term “fibromyocytes” (FMC) and inhibit SMC transition to a
“chondromyocyte” (CMC) phenotype that is advanced by disease promoting genes such as PDGFD and
TWIST1. In this renewal application we propose to extend these studies by investigating upstream signaling
mediated by two TGFB superfamily members that link the BMP and TGFB pathways in a causal CAD
regulatory network. Specifically, in this application we will pursue investigation of functional cellular interactions
that are mediated by CAD associated factors BMP1 and TGFB1, which are linked in a feed-forward
autoregulatory loop that impacts extracellular matrix (ECM) components and growth factors to mediate CAD risk
through previously unexplored disease mechanisms. BMP1 is the primary regulator of TGFB1 bioavailability
through post-translational prodomain processing, and as a metalloproteinase also directly activates other
TGFB growth factors and extracellular matrix molecules such as collagens and lysyl oxidases that can promote
stability of the fibrous cap. In keeping with previous studies, causal gene TGFB1 is expected to mediate SMC
disease transition phenotypes through canonical signaling, but is also expected to mediate SMC cell state
changes through unexplored non-canonical signaling pathways. We hypothesize that protein products of
these two prominent CAD genes, BMP1 and TGFB1, regulate each other’s expression and function to
modulate SMC phenotype transitions, ECM composition, and thus lesion integrity in the context of a
CAD gene causal nexus. Thus, to better understand how BMP1 and TGFB1 interact to modulate the function
of other growth and matrix factors that determine structure and stability of the plaque and fibrous cap, we
propose the following Aims. Aim 1 studies will investigate the cellular anatomy of vascular lesions, as well as
genome wide transcriptomic effects of SMC-specific Bmp1 modulation, in a mouse atherosclerosis model. In
Aim 2, we will perform identical studies investigating genetic manipulation of Tgfb1 and compare transcriptional
and lesion features of these two linked CAD causal factors. In Aim 3, we will use in vitro SMC models to further
investigate how BMP1 regulates TGFB1 bioavailability and function of other ECM molecules involved in SMC-
specific disease processes. These studies will significantly expand our understanding of genetic CAD
mechanisms and identify targetable genes and pathways for new approaches to the treatment of CAD.

Public health relevance
PROJECT NARRATIVE (Public Health Relevance) Significant expense and effort by groups of scientists around the world has identified regions of the human genome that are associated with the genetic risk for various forms of cardiovascular disease, including coronary artery disease. Additional research is required to understand the specific genes involved, and how they work to contribute to the disease process. Such information will allow for better risk assessment and the development of better therapeutics for these diseases.